Impaired TRVP4-eNOS signaling in TM contributes to glaucoma

Abstract
Primary Open Angle Glaucoma (POAG) is the most common form of glaucoma that leads to irreversible vision
loss. Elevated intraocular pressure (IOP) due to dysfunction of trabecular meshwork (TM) tissue is a hallmark of
POAG. However, the pathological mechanisms leading to TM dysfunction and IOP elevation are poorly
understood. TM has an intrinsic ability to maintain IOP homeostasis by sensing the changes in the flow of
aqueous humor (AH). In this regard, we recently showed that Ca2+ influx through transient receptor potential
vanilloid 4 ion channels in the TM (TRPV4TM channels) lowers IOP via activation of endothelial nitric oxide
synthase (eNOS)–NO signaling. Importantly, we showed that TRPV4TM-eNOSTM signaling is impaired in
glaucomatous primary human TM cells. The major goals of this application are to elucidate the pathological
mechanisms that impair TRPV4TM-eNOSTM signaling in glaucoma and to target them for rescuing the TM
function. Chronic endoplasmic reticulum (ER) stress is a crucial contributor to TM dysfunction and IOP elevation
in glaucoma. In our preliminary studies, we observed that chronic ER stress activates inducible NOS (iNOS), an
enzyme commonly associated with the formation of oxidant molecule peroxynitrite (PN). PN levels are elevated
in TM tissues from POAG donor eyes and exogenous PN reduced TRPV4TM channel activity in human primary
TM cells. Moreover, induction of ER stress also lowered TRPV4TM channel activity. Therefore, we hypothesize
that PN-induced inhibition of TRPV4TM-eNOSTM signaling contributes to TM dysfunction and IOP
elevation in glaucoma. The major objectives of this application are to determine whether chronic ER stress
leads to TM dysfunction and IOP elevation via PN-induced lowering of TRPV4TM-eNOSTM signaling in glaucoma,
and to target this pathology for the treatment of glaucoma. In Aim 1, we will determine whether chronic ER stress
lowers TRPV4 channel activity in TM cells. In Aim 2, we will determine whether PN levels are elevated in
glaucoma and whether PN lowers TRPV4 channel activity in TM. We will also determine whether chronic ER
stress underlies elevated PN levels in glaucoma. In Aim 3, we will target PN pathology to lower elevated IOP in
mouse and human models of ocular hypertension. This proposal utilizes complementary expertise of Dr. Zode’s
laboratory in glaucoma research and ER stress, and Dr. Sonkusare’s laboratory in TRP ion channel imaging and
electrophysiology. This study will utilize state-of-art Ca2+ imaging, patch-clamp, eNOS activity, and nitric oxide
measurements in primary human TM cells and TM tissues, human perfusion cultured donor eyes, and mouse
models of glaucoma. Successful completion of the proposed studies will provide novel pathological mechanisms
and therapeutic targets for the treatment of general POAG.

Public health relevance
PROJECT NARRATIVE The successful completion of this project will lead to insights into molecular pathways that cause trabecular meshwork dysfunction and elevation of intraocular pressure in glaucoma, a leading cause of irreversible vision loss. Furthermore, our proposed studies will target these pathological mechanisms for the treatment of glaucoma.